EIB Microscopy Core Facility

The Facility operating expenses primarily include the cost of annual instrument specific service contracts, covering two laser scanning confocal microscopes, widefield epifluorescence microscope and STED superresolution microscopy system, and purchase of necessary equipment and software upgrades. As new technology becomes available, novel imaging procedures are developed and continually refined to take advantage of the full capabilities of the instruments. Image processing and analysis are developed to quantify and standardize observations made using the imaging based assays. Dr. Wisniewski's works to develop new microscope based assays. The Facility provides start up consumable reagents that are replenished by the user.